Elucidating the Role of Perivascular Niche in Glioblastoma Invasion and Therapeutic Resistance at Single Cell Resolution using Biomimetic Tumor Microenvironment Models

Summary
One of the critical challenges in the treatment of Glioblastoma (GBM) is the presence of highly resistant cells
with stem-like properties, called glioma stem cells (GSCs), that evade surgical resection, resist conventional
treatments and are primarily responsible for tumor recurrence. The perivascular niche within the GBM tumor
microenvironment (TME) has been well recognized as a critical site that shelters GSCs and promotes their
stemness, invasion, and therapeutic resistance.
Extensive studies from others and our lab, using in vitro and in vivo models, have demonstrated that the
crosstalk between the endothelial cells (ECs) and GSCs regulates GSC proliferation, tumorigenicity and self-
renewal capacity. However, the perivascular niche is a complex microenvironment comprised not only of ECs
but multiple other cell types including astrocytes, pericytes, and immune cells. How the cell-cell interactions
between the various cellular components of the perivascular niche modulate GSC behavior (proliferation vs.
quiescence and invasion vs. homing) and therapy resistance is poorly understood. To address these unmet
biological knowledge gaps, there is a critical need for sophisticated and more realistic ex vivo tumor models that
better recapitulate the physiological complexities of the GBM perivascular niche to advance our fundamental
understanding of the biology of the disease and predict therapeutic responses.
Recently, we have established and validated an on-chip microfluidic tumor model of GBM, with a unique 3D
organotypic architecture, to study the influence of the perivascular niche on GSC invasion. We have shown that
co-culturing of astrocytes enhances EC-induced invasion of GSCs, where RNA-seq analysis of mono-culture vs.
tri-culture provided a mechanistic insight into the receptor-ligand pairs that mediate the interactions between
cells. Based on these foundational developments, in this study our goal is to develop an ex vivo tumor model of
GBM, bioinspired from the native perivascular niche, with patient-derived cells to dissect the role of cellular
components within the niche on GSC biology and response to treatment at single cell resolution.
In Aim 1, our objective is to determine the influence of the key cell types within the perivascular niche on
GSC-EC interactions. In Aim 2, we plan to mechanistically unveil the impact of radiation treatment on GSCs-
perivascular niche interactions, while in Aim 3, we will blunt invasion and sensitize GSCs through disruption of
niche-tumor cell interactions. Our study design uniquely employs an interdisciplinary approach including
microengineering of a bioinspired ex vivo tumor model, single-cell level resolution analysis, molecular-level
transcriptomics, and validation using ex vivo patient tumor samples. Successful completion of these studies will
not only further our understanding of the interactions of GSCs with the perivascular niche but will also facilitate
identification of novel targets to block disease progression.

Public health relevance
Narrative The perivascular niche within the GBM tumor microenvironment (TME) protects glioma stem cells (GSCs) from genotoxic damage, promotes their stemness, and invasion. Despite its importance, how the cell-cell interactions between various cellular components of the perivascular niche modulate GSC behavior (proliferation vs. quiescence and invasion vs. homing) and therapy resistance is poorly understood. In this study, we propose to develop ex vivo microengineered and bioinspired model of the GBM perivascular niche to mechanistically examine, at single cell resolution, the role of cellular components within the niche on GSC biology and response to treatment.